Project 3: Notch signaling in oHSV therapy for GBM

PROJECT SUMMARY – PROJECT 3
NOTCH signaling is aberrantly activated in GBM and is important for maintenance of GBM initiating cells, as well
as angiogenesis. Therefore, therapeutic strategies that can modulate NOTCH signaling are of particular interest
for GBM. Our preliminary unpublished results have uncovered that treatment with gamma secretase inhibitor
(GSI) that inhibits the NOTCH intracellular domain (NICD) release and hence NOTCH activation improves
virotherapy of GBM in vivo in mice bearing intracranial GBM. We have further discovered that oHSV (and
miRH16 encoded by oHSV) induce increased Jagged-1 (Jag1) one of the five NOTCH ligands on infected GBM
and also increases NOTCH signaling activity in uninfected tumor cells and the tumor microenvironment.
Increasing evidence suggests that NOTCH activation plays a significant role in macrophage activity and
polarization. Further, our data also show that blockade of oncogenic NOTCH signaling improves anti-tumor
efficacy of oHSV in vivo. Thus, we hypothesize that: (a) increased Notch ligand expression in oHSV1-infected
tumor cells will result in increased NOTCH activity in uninfected tumor cells (Aim 1), (b) NOTCH activity in
macrophages increases tumor inflammation (Aim 2), and (c) inhibiting NOTCH activity in conjunction with oHSV1
therapy will increase efficacy (Aim 3). Thus blocking NOTCH signaling with oHSV therapy should have
significant clinical and translational implications.

Public health relevance
PROJECT NARRATIVE – PROJECT 3 Despite decades of research, prognosis for patients suffering from malignant glioblastoma (GBM) remains poor. Oncolytic viral (OV) therapy is an exciting therapeutic modality that has been approved for non resectable melanoma, and is being evaluated for safety and efficacy in patients with GBM. The proposed research in this project will investigate impact of this therapy on tumor and stromal cells and with a goal to improve virotherapy.